Glycomic Modulation of Inflammaging and Immune Functions during HIV Infection

PROJECT SUMMARY: There is an urgent need to identify biomarkers that can predict the development of
inflammation-associated comorbidities in people with HIV (PWH) on antiretroviral therapy (ART), as well as to
develop novel strategies to prevent or treat these comorbidities. Our recent data suggest that glycomic
alterations in circulating IgGs are not only candidates for such biomarkers but they may also mechanistically
contribute to HIV-associated inflammation by compromising antiviral immuity in a manner that can be normalized
In the general population, IgG glycomic alterations drive inflammatory responses during aging (inflammaging).
In a recent publication (Giron et al., Nature Communications, 2024), we found that living with ART-suppressed
HIV infection is associated with an acceleration in the accumulation of pro-aging IgG glycomic alterations.
Specifically, antibodies from PWH on ART showed a significant loss of the anti-inflammatory glycans galactose
(agalactosylation) and sialic acid (hypo-sialylation) compared to HIV-negative controls. These alterations
were associated with greater inflammation and increased severity of inflammaging-associated comorbidities in
PWH on ART. In proof-of-concept studies, we also found that these alterations might precede the development
of such comorbidities by years, making them viable candidates for discovering predicitive biomarkers.
Beyond their potential as biomarkers, agalactosylation and hypo-sialylation could also constitute causative
mechanisms contributing to inflammation in PWH on ART: 1) Agalactosylation: Glycans on IgGs regulate the
binding of IgGs to their Fc receptors, defining the ability of IgGs to elicit anti-viral innate immune functions. We
examined whether the lack of galactose on IgGs compromised their anti-HIV Fc-mediated immune functions; we
glyco-engineered the HIV antibody 10-1074 to produce agalactosylated and highly-galactosylated glycoforms.
Agalactosylated glycoforms exhibited significantly lower anti-HIV immune function than highly-galactosylated
glycoforms. We propose that this compromised anti-HIV immune function, caused by IgG agalactosylation,
impairs the immune system's ability to control virally-infected cells, leading to greater inflammation. Consistent
with this hypothesis, we found IgG agalactosylation during ART correlated with elevated levels of HIV DNA during
ART and faster HIV viral rebound after stopping ART. 2) Hypo-sialylation: Sialic acid can initiate an anti-
inflammatory response by binding to inhibitory molecules on myeloid cells. Loss of sialic acid hinders this
mechanism. Our data support this mechanism by showing that treating humanized mice (no ART) with sialidase
inhibitors (to prevent hypo-sialylation and preserve sialic acid) attenuated viremic HIV-associated inflammation.
These data support our overarching hypothesis that agalactosylation and hypo-sialylation: 1) can serve as
predictive biomarkers for inflammaging-associated comorbidities in PWH on ART (Aim 1); 2) are mechanistically
linked to HIV persistence and inflammation by compromising anti-viral Fc-mediated innate immune functions
(Aim 2a, 2b); and 3) can be normalized to enhance immunity and inhibit inflammaging (Aim 2b, Aim 3).

Public health relevance
PROJECT NARRATIVE As people with HIV grow older, they face health issues tied to inflammation, such as heart disease and cancer, even when the virus is controlled by antiretroviral therapy. This study aims to figure out what causes this inflammation, hypothesizing that the loss of specific anti-inflammatory carbohydrate molecules (glycans) circulating in the body contributes to the development of HIV-related inflammation, which could lead to associated health problems. The idea is that if changes occur in these glycan structures during the course of living with HIV, understanding these changes could open the door to identifying new biomarkers for predicting age-related illnesses in people with HIV, as well as developing novel strategies to correct these glycans and reduce inflammation.